Connectivity and function of inhibitory neurons in the primate visual cortex

PROJECT SUMMARY
In the mammalian neocortex, inhibitory neurons (INs) profoundly influence cortical computations and
dynamics, and their various functions are thought to be mediated by different IN types. While a large diversity
of INs exists, molecular markers in mouse cortex identify three major non-overlapping classes: parvalbumin-
(PV), somatostatin- (SOM), and vasoactive intestinal peptide- (VIP) INs. Studies in mouse lines expressing
Cre-recombinase in each of these IN classes are rapidly revealing distinct patterns of connectivity, response
properties and in vivo function for each class. However, it remains unknown whether insights gained from
mouse cortex apply to cortical INs in primates and humans. IN dysfunction in humans has been implicated in
several disorders, such as epilepsy, schizophrenia, anxiety and autism, therefore it is important to understand
normal cortical IN connectivity and function in primates. The lack of viral tools to selectively access IN
subtypes, and the difficulty of performing genetic manipulations in primates have been major impediments to
studying INs in this animal model. Our goal is to leverage recent advances in the development of viral tools to
express transgenes in specific INs subtypes to investigate the connectivity, response properties, and
computational function of two major classes of INs, PV and SOM, in the superficial layers of the primate
primary visual cortex (V1). Using IN-type specific expression of Cre-recombinase combined with rabies-virus
monosynaptic circuit tracing, we will map local and brain-wide inputs to specific V1 IN classes (Aim1). Using
two-photon imaging of IN-type specific targeted calcium indicators, or optogenetic identification of
channelrhodopsin-tagged IN types, we will characterize the visual response properties of distinct V1 IN classes
(Aim2). Finally, we will use optogenetic inactivation of distinct IN-types expressing inhibitory opsins, to
understand the relative roles of IN classes in V1 computations (Aim3). We will test specific hypotheses derived
from available data in mouse, the specific geometry of PV and SOM cells in primate cortex, published
computational models of feature tuning and surround suppression in visual cortex, and our preliminary
results. Impact. The proposed studies will provide the first account of the connectivity, visual properties and
computational function of PV and SOM INs in primate cortex, paving the way for studies of IN function in this
order. They will also reveal conserved principles of IN function across species, as well as fundamental inter-
species differences, stressing the importance of studying cortical function in species that are evolutionarily
closer to humans.

Public health relevance
NARRATIVE Normal brain function depends on the orderly development of circuits in the cerebral cortex and on their intact function. Knowledge of the normal circuitry provides a foundation for understanding the causes of impaired brain function and developing corrective measures. Our studies of the normal circuitry involving inhibitory neurons in early visual cortical areas will provide greater insight into the causes and effects of central vision defects when these circuits are damaged by stroke or other neurological or developmental cause. Moreover, our studies of inhibitory neuron function will provide a foundation for understanding the consequences of their dysfunction in neurological and psychiatric disorders, such as seizure disorders (Zhang et al., 2009; Halabisky et al., 2010; Peng et al., 2013) and schizophrenia (Hashimoto et al., 2003; Volk et al., 2012), which have been associated with alterations in gene expression, abnormal function or anatomy of distinct types of inhibitory neurons, including PV and SOM neurons.